Clinical and Translational Research

We do not list human specimens in this report, even though they are used in our research. The required survey is given as part of the LAM annual report or by other investigators participating in this annual report, as necessary, through their specific annual reports (e.g., Stewart Levine (asthma)). Further, protocols run under the auspices of these investigators were used as the basis for the collection of samples from participating research subjects (e.g., Stewart Levine, Joseph Fontana). We provide assistance for the investigators in the conduct of the studies.